Leveraging a 'sliding-window' Type I CRISPR base editing platform to correct CFTR null mutations

Project Summary
Cystic Fibrosis (CF) is an autosomal recessive genetic disorder affecting nearly 160,000 patients worldwide. It
is caused by mutations in the CF transmembrane conductance regulator (CFTR) gene, which encodes a
chloride ion channel crucial for salt and water homeostasis across epithelial membranes. CFTR dysfunction
leads to severe damages to the lungs, intestines, and pancreas. Recent advancements have been made in CF
drug development, with 90% of CF patients able to benefit from small molecule drugs, CFTR modulators.
However, these medications are expensive, can have serious side effects, and must be taken for a lifetime as
they do not provide a permanent cure. Nor do they not address the unmet medical need of the remaining 10%
of CF-patients with CFTR null mutations. Alternative therapeutic strategies are urgently needed to alleviate the
disease burden on society. CRISPR-Cas gene editing therapy promises a permanent cure for CF by directly
fixing the genetic root cause of the disease. Since only individuals with two copies of the defective CFTR gene
will develop CF, correcting a single copy at the endogenous gene locus should be adequate for a cure. This
proposal aims to develop a gene editing strategy for CFTR-G542X, the second most common CF mutation and
the most prevalent null mutation, rendering it non-responsive to CFTR modulator drugs. We will leverage Type
I CRISPR, which offers unique properties not attainable with traditional Cas9 tools derived from Type II
CRISPR. The overall strategy is to install a high-efficiency, precise single base change to correct the
pathogenic adenine underlying G542X into a functional CFTR variant. In Aim 1 and Aim 2, I will determine the
editing efficacy and safety for strategy in a patient-derived induced pluripotent stem cell line model. In Aim 3, I
will assess the therapeutic outcome by measuring CFTR channel function restoration in a preclinical human
bronchial epithelial cell line model. Successful completion of these objectives will provide proof of concept for
Type I CRISPR base editing therapy to treat patients with CFTR null mutations. Our long-term goal is to
establish a framework for treating a variety of CFTR mutations using a unified Type I CRISPR platform with
unprecedent targeting scope.

Public health relevance
Project Narrative Cystic Fibrosis (CF) a life-threatening genetic disorder that results in significant morbidity and mortality due to damages to the lungs and digestive systems. Despite pharmaceutical success in developing small molecule drugs that modulate CFTR protein function, CF patients still face limitations with these drugs including high cost, the need for lifelong use, and their lack of effectiveness for CFTR null mutations. This proposal aims to leverage our new Type I CRISPR gene editing tool to develop a therapeutic strategy to correct the second most prevalent CF-causing mutation, the CFTR G542X null variant.